Convener and Organizer of Activities and Engagements Related to Processes, Surveillance, and Policy Development of Medical Products for Ongoing Public Health Activities, U01 Clinical Trial Not Allowed

PROJECT SUMMARY
The Center for Drug Evaluation and Research (CDER) at the U.S. Food and Drug Administration's (FDA or the
Agency) is seeking proposals for collaborative research and convening activities to advance regulatory science,
policy, and procedures to address a range of critical public health topics, including drug development, drug
approval, bioresearch monitoring, human subject protection, and postmarket surveillance. Building on over
fifteen years of experience working collaboratively with the FDA on such topics, the Duke-Robert J. Margolis,
MD, Institute for Health Policy at Duke University (Duke-Margolis) proposes to continue engaging with teams at
FDA/CDER to jointly tackle a range of priority public health issues, leveraging our access to a wide variety of
experts within the Duke ecosystem and our strong relationships with a diverse range of external stakeholders to
advance aims in the following areas:
Specific Aim 1: Execute collaborative research projects with FDA to support the Agency and its stakeholders by
exploring and addressing a range of critical and pressing public health topics related to FDA's oversight of
medical products, policy, and surveillance methods and systems. Our approach incorporates a wide array of
stakeholder perspectives, including those from emerging areas and/or new to engaging with FDA, to explore key
topic areas through impactful convenings, facilitate the identification of practical and actionable solutions, support
the Agency in its essential public health activities, and bring benefits to patients.
Specific Aim 2: Synthesize and distill the research, stakeholder input, and event discussions in Aim 1 to identify
concrete, actionable next steps and recommendations for all stakeholder groups, including FDA, to pursue. In
achieving this aim, we will develop a range of audience-tailored deliverables that lay out avenues for progress.
Specific Aim 3: Disseminate the findings and recommendations developed under Aim 2 to key stakeholders and
the public in a transparent manner, promoting trust and driving policy advancement in priority areas. Convening
and research materials will be posted publicly on Duke-Margolis event webpages as appropriate and findings
shared through those and other venues selected to reach broad audiences and drive progress.

Public health relevance
PROJECT NARRATIVE The U.S. Food and Drug Administration (FDA), through its Office of Medical Policy, has sought to advance regulatory science, policy, and procedures to address a range of critical public health topics, including drug development, drug approval, bioresearch monitoring, human subject protection, and post market surveillance methods and systems. The Robert J. Margolis, MD, Institute for Health Policy at Duke University (Duke- Margolis) proposes to support the FDA in advancing its medical policy development through rigorous collaborative research and convening activities from design, planning, and execution, through to synthesis, drafting, and communication of findings. This builds on Duke-Margolis and FDA's 15-year track record of partnership and leverages Duke-Margolis's skill as a neutral third-party convener to develop and deliver trusted, high-impact stakeholder engagement and research materials on priority regulatory and public health issues.